Impacts of non-antibiotic medications on microbiome-mediated protection against intestinal pathogens

PROJECT SUMMARY
Antibiotic usage disrupts intestinal homeostasis and is associated with an increased risk of infections in humans.
Recent evidence suggests that non-antibiotic prescription medications can change microbiome composition, but
how drug-microbiome interactions impact the risk of gastrointestinal (GI) disease is unexplored. To address this
gap in knowledge, we analyzed health records, including hospitalization, drug prescription data, and pharmacy
claims, for over 1 million anonymized individuals spanning 15 years to identify medications associated with
increased risk of GI infection. We identified expected associations, including anti-infectives and
immunosuppressive agents, that increase infection risk. Notably, we also identified unexpected associations:
other prescription medications that elevate infection risk to a similar degree as antibiotics and
immunosuppressants but do not fall into either of these drug classes. The central hypothesis of this proposal
is that treatment with non-antibiotic prescription medications disrupts the microbiome to increase the risk of
intestinal infections. We established a mouse model of Salmonella enterica subsp. Typhimurium (S. Tm) infection
for two of these drugs (the cardiac drug digoxin and the anticonvulsant clonazepam), and demonstrated that
drug administration increases infection risk and also alters microbiome composition. In our initial (proof-of-
concept) studies, we established that the impact of digoxin on infection risk is transmissible via the microbiome.
Specifically, digoxin decreases the abundance of a key group of immunomodulatory bacteria (segmented
filamentous bacteria; SFB) in the mouse gut, and restoring the abundance of these bacteria rescues mice from
increased infection susceptibility. Notably, clonazepam also increases infection risk, but in an SFB-independent
manner. Building on this work, in Aim 1 of this proposal, I will 1) determine how digoxin alters SFB levels in the
mouse gut and 2) examine whether human microbiome variability alters digoxin effects on the microbiome and
S. Tm infection. I will use a similar approach in Aim 2 to examine whether clonazepam increases pathogen
colonization by disrupting the microbiome. Through these aims, I will enrich my experience in mucosal
immunology, analysis of large datasets, epidemiological study designs, and mouse models of infection (K99
phase). To enable this training, I have established a mentoring and advisory team consisting of experts in drug-
microbiome studies, S. Tm pathogenesis, mucosal immunology, and epidemiological study designs. As I
transition into independence, I will build on this unique foundation to define mechanisms of the impacts of
prescription medications on the gut microbiome and infection risk (R00 phase). These studies will allow us to
understand the effects of these bioactive compounds on the gut microbial communities, which are important in
maintaining gut health. The underlying molecular mechanisms discovered by the completion of this study will
enable us to develop strategies for mitigating GI diseases using microbiome-mediated interventions.

Public health relevance
PROJECT NARRATIVE A fundamental understanding of how intestinal bacteria and the host immune system resist gut pathogen colonization is essential in developing new therapeutics against gut infections. Non-antibiotic medications can disrupt the microbiome-mediated protection barrier and lead to intestinal diseases. The proposed studies will identify mechanisms through which non-antibiotic prescription medications can disrupt the gut microbiome and will provide avenues to generate microbiome-based therapeutics against infectious gastrointestinal diseases.